RNAi Analysis and Screening for Study of Genes and Anti-Cancer Treatments

RNAi-based technologies have the potential to enhance many aspects of the anti-cancer drug development process. The increased use of anti-cancer therapeutics targeting specific genetic characteristics (e.g., a fusion transcript or over-expression/amplification of a gene) illustrates the impact molecular analysis has had on the development of anti-tumor agents. Further, there is growing awareness that the genetic background of an individual can influence a patients response to anti-cancer therapeutics. Studies focused on assessing the contribution of genetic and transcriptional variation to a drug response phenotype have become more sophisticated as larger data sets integrating drug-activity with genome-wide DNA/RNA analysis are reported. However, functional approaches to understanding the relationships predicted by these studies have been lacking. We are using RNAi analysis and screening to probe the impact of gene-specific expression on drug-activity, including identification of new proteins that directly or indirectly modulate the pharmacology of anti-cancer therapeutics. We have used the power of RNAi analysis to investigate gene-drug interactions, including study of multi-drug resistance and the activity of the anti-leukemia agent L-Asparaginase. We have also initiated screens that combine RNAi with drug administration. The identification of molecular targets that can act to modulate the activity of anti-cancer drugs has become an important application for RNAi screening approaches. This approach combines RNAi with administration of a small molecule compound or biologic to identify proteins whose down-regulation modulates the activity of a therapeutic agent. This approach has the potential to enhance the clinical application of an established or investigational drug by: (1) identifying synergistic molecular targets that exploit complementary vulnerabilities within a cancer cell, (2) enabling the use of lower concentrations of a drug that exhibits dose-dependent non-specific toxicities, (3) overcoming drug resistance, and, (4) broadening the clinical application of a drug to other cancer types. We began our drug-RNAi screening projects focusing on a chemosensitization (synthetic-lethal) approach using a clinical relevant drug with a defined molecular target and mode of action, the topoisomerase 1 inhibitor camptothecin (CPT), to enable validation of our screens in the context of established drug activity. We recently published a study that identified TGF beta activated kinase 1 TAK1 as a sensitizing target of CPT. Silencing of TAK1 through RNAi enhances the sensitivity of several cell types to CPT. We also identified TAB2 a binding partner of TAK1 and TRAF6, an upstream activator of TAK1 as sensitizing targets of CPT. This work is likely to enhance our understanding of the cell response to the DNA damage induced by topoisomerase 1 inhibitors and could be used as the basis of improved application of these inhibitors through the use of agents that target the TRAF6/TAK1/TAB2 signaling response. We are currently using RNAi screening strategies to examine drugs with less defined or more complex mechanisms of action and/or drugs undergoing pre-clinical or early clinical testing including TRAIL peptide and mithramycin.